SigH based attenuated, efficacious Mtb vaccines to protect against lethal TB

Abstract
Infection with M. tuberculosis (Mtb) can cause TB, which is now the leading global cause of
mortality due to a single infectious disease agent. The failure to control TB stems from the lack of
an effective vaccine. BCG, the vaccine currently in use, is unable to generate long-lived memory
responses and protect against pulmonary TB in adults. New vaccines against TB are therefore,
urgently needed. Our work has shown that the ΔsigH mutant of Mtb is attenuated for replication
and disease in macaques). Aerosol vaccination with this mutant induces strong lung immune
signatures that protect against lethal TB. Nonpathogenic ΔsigH infection in macaques is not
reactivated by SIV co-infection. Additional unrelated mutation(s) are however needed in ΔsigH
to ensure its complete attenuation. This project aims to develop a ΔsigH -based human TB vaccine
candidate that could eventually advance to clinical development. ΔsigH deletion will be added to
10 recombinant Mtb strains. Some of these mutants generate immune enhancement- or
auxotrophy-based attenuation phenotypes, while others render Mtb avirulent in macaque lungs.
We will assess the safety of these ten strains in SCID mice and progressively smaller numbers in
immunocompetent and SIV co-infected macaques by multiplexing. Two strains that consistently
provide the best results in terms of safety/immunogenicity will be evaluated in detail for
immunogenicity and efficacy via aerosol (AER) vaccination relative to BCG- and ΔsigH -
vaccination, in a physiologically relevant macaque model.

Public health relevance
Narrative This project aims to develop a ΔsigH-based human TB vaccine candidate that will advance to clinical development. We will attempt to develop a new effective vaccine against TB using aerosol-delivered mutant Mtb as an approach. ΔsigH deletion will be added to 10 other mutant Mtb strains and their safety/efficacy phenotype progressively evaluate in different models for down-selection. Finally, the efficacy of two strains will be evaluated in a relevant macaque model and one strain chosen for clinical development.